Using genetically informed designs to understand the impact of parental divorce/separation and parental marital discord on offspring alcohol outcomes

Project Summary
The objective in this proposal is to advance the understanding of the mechanisms through which parental
divorce/separation and marital discord influence offspring alcohol use disorder (AUD) and related outcomes
(e.g., earlier age at first drink and alcohol misuse). It is commonly thought that parental divorce/separation and
parental marital discord have direct, pathogenic effects on offspring alcohol outcomes. Yet, there is a limited
appreciation of the role of genetic factors in these associations, despite suggestive evidence that offspring
exposed to parental marital problems also inherit AUD genetic predispositions, and that AUD genetic
predispositions can sensitize individuals to the adverse effects of environmental stressors. This underscores
the need to study the confluence of genetic factors and these common family adversities to understand their
joint legacy on offspring alcohol outcomes. The goal here is to address this gap using data from two
intergenerational, genetically-informative studies. The first is the Virginia Adult Twin Study of Psychiatric and
Substance Use Disorders, a sample of European ancestry twins (N=9345, 45% female) recruited from birth
records for whom direct psychiatric interview data were collected on all twins plus a subset of parents
(N=1472, 58% female), with additional parental data collected via diagnostic psychiatric family history
interviews with the twins. The second is the Collaborative Study on the Genetics of Alcoholism (N=11561, 53%
female), a molecular genetic study of an ethnically diverse (69% European American, 31% African American)
sample of families primarily recruited via treatment-seeking probands for whom psychiatric interview data were
collected from all participants. These two samples are mutually informative in permitting examination of the
generalizability and convergence of findings across different methods and populations. Guided by a bio-
ecological framework, the aims are to: (1) examine the extent to which associations between parental
divorce/separation, parental marital discord, and offspring alcohol outcomes reflect direct (i.e., ‘causal’) effects
versus shared genetic effects; and (2) examine whether offspring genetic factors predict variability in their
responses to parental divorce/separation and parental marital discord. The results may have theoretical
implications for the indirect, environmental pathways through which genetic risk for alcohol problems is
transmitted in families (i.e., gene-environment correlation), as well as an understanding of how genetic
influences confer sensitivity to familial stressors (i.e., gene-environment interaction). In turn, the results may
inform clinicians’ psychoeducation efforts to prevent alcohol misuse among offspring from families
experiencing marital distress and divorce. More broadly, this work will contribute to the long-term goal of the
Early Stage Investigator PI’s program of research to delineate how genetic factors and close relationship
factors come together to influence the onset, persistence, and discontinuity of alcohol misuse.

Public health relevance
Project Narrative The proposed research is relevant to NIH’s public health mission because it investigates how genetic factors and familial stressors (i.e., parental divorce/separation and parental marital discord) come together to influence socially costly alcohol use disorders. Ultimately, the results may have downstream implications for the psychoeducation that intervention programs and clinicians provide families experiencing marital distress and divorce.